Translation Regulation Contributes to Hypoxia Adaptation in Glioblastoma

PROJECT SUMMARY
Glioblastoma (GBM) is a CNS tumor derived from glial cells. It is the most common and fatal primary malignant
brain tumor in adults with a median survival of 15 months. Current treatment strategies involve surgical resection
followed by radiotherapy with concurrent chemotherapy. Unfortunately, GBM is highly resistant to therapy and
will inevitably recur, resulting in poor patient outcomes. GBM has been described as having an oxygen-deprived
niche and a perivascular, oxygen-rich, niche. Deeper characterization of these tumor environments has revealed
the presence of cellular heterogeneity, angiogenesis, and invasion in both niches. The critical cellular player
involved with these tumor behaviors is the glioblastoma stem-like cell (GSC). GSCs seem to reside in both
hypoxic (low oxygen level) and normoxic (normal oxygen level) niches yet maintain their stemness and self-
renewal capacities across both conditions. Strategies to target these GSCs have proven to be unsuccessful so
far but remain a promising avenue for research. There is a need to develop a greater understanding of GSC
biology, starting with the regulatory mechanisms with which they adapt to the hypoxic environment of GBM and
promote tumor growth. However, most studies exploring GSCs are performed in normoxic conditions. Further,
the central aspect of post-transcriptional gene regulation, translation, where genetic information is converted to
functional proteins, remains relatively unexplored. The objective of the proposed research is to study the
translation (mRNA-to-protein) regulatory step of protein synthesis in GSCs, as opposed to the more commonly
explore transcription (DNA-to-mRNA) regulatory step, with the desired outcome of illuminating systemic
programs for hypoxic adaptation. To accomplish this objective, our approach in Aim 1 will use ribosome
profiling (RIBO-seq) in conjunction with RNA sequencing (RNA-seq) to offer a quantitative understanding
of transcriptional and translational regulatory pressures on mRNA transcripts. I will utilize both techniques to
clarify the influence on hypoxia on translational gene regulation in GSCs. I expect to find genes and gene-sets,
representing biological pathways, that are modulated by hypoxia predominantly through translational regulation,
revealing a novel list of candidates for future therapy. To validate this discovery framework, I will perform an array
of functional studies on selected genes. In parallel, Aim 2 will focus on a particular set of translational
machinery known as the Integrated Stress Response (ISR), whose members sense cellular stress and
modulate translation of survival-associated transcripts. With burgeoning evidence of aberrant ISR behavior in
malignant cells, interrogating the mechanism through which the ISR may mediate translational changes in
hypoxic GSCs will present another avenue through which to halt such adaptive behaviors. Altogether, this
proposal will promote further understanding of GSC biology, with respect to translation regulation, thereby
unveiling novel targets for future GBM therapy and ultimately contribute to brain tumor patient care.

Public health relevance
PROJECT NARRATIVE Glioblastoma (GBM) is a highly malignant primary brain tumor and with a median survival of 15 months despite aggressive surgical and chemotherapeutic interventions. Glioblastoma stem-like cells (GSCs) are the key cells responsible for initiating this tumor and they can adapt to the complex environment in the brain, even areas of low oxygen. This project will help us develop a deeper understanding of GSC biology, especially the tools of translation regulation (mRNA-to-protein), as they are corrupted for use in stressful low-oxygen conditions thereby revealing a novel list of targets for future therapy in GBM patients.